Role of LMPTP in cardiac fibrosis

PROJECT SUMMARY
The objective of this proposal is to determine the mechanism of action of the low molecular weight protein
tyrosine phosphatase (LMPTP) in cardiac fibrosis.
Cardiac fibrosis is a major contributor to the pathogenesis of heart failure. In cardiac tissue, fibrosis prompts
pathological changes that include dilation and hypertrophy, and ultimately leads to heart failure. There are no
FDA-approved anti-fibrotic medications for heart failure; therefore, novel agents to alleviate cardiac fibrosis are
a major unmet medical need in cardiology.
This proposal focuses on the tyrosine phosphatase LMPTP, which is encoded by the ACP1 gene. LMPTP has
been considered an inhibitor of signaling through receptor tyrosine kinases by dephosphorylation of tyrosine
residues in their activation motifs. In humans, genetic polymorphisms in the ACP1 gene encoding for high
LMPTP activity are known to promote myocardial hypertrophy. We previously reported that LMPTP expression
is significantly upregulated in hearts of humans with end-stage heart failure. We generated the first LMPTP
knockout mice and found that when subjected to blood pressure overload through transverse aortic constriction
(TAC), they are protected from cardiac hypertrophy and failure, and develop substantially decreased fibrosis in
the heart. We also found that inhibiting LMPTP with a small-molecule chemical inhibitor that we developed
leads to reduced cardiac fibrosis, hypertrophy, and failure in TAC-treated mice. Taken together, these findings
suggest a novel role for LMPTP as a promoter of cardiac fibrosis and failure.
Here we propose a series of mechanistic experiments to elucidate the physiological and molecular
mechanisms of action of LMPTP in fibrosis-associated heart failure. We will (Aim 1) demonstrate that LMPTP
promotes cardiac fibrosis in multiple mouse models, (Aim 2) determine the cell type by which LMPTP promotes
cardiac fibrosis, and (Aim 3) determine the molecular mechanism of action of LMPTP in promoting cardiac
fibrosis and failure.

Public health relevance
PROJECT NARRATIVE Cardiac fibrosis is a major contributor to the pathogenesis of heart failure. We found that a protein belonging to a unique subclass of tyrosine phosphatases is significantly upregulated in humans with end-stage heart failure, and that knockout or inhibition of this protein protects mice from cardiac fibrosis and failure. The objective of this application is to understand the physiological and molecular mechanisms of action of this protein in cardiac fibrosis.